Modifiers of Down Syndrome Co-occurring Phenotypes

ABSTRACT
Individuals with Trisomy 21 (Ts21) have ~80 defined clinical phenotypes collectively known as Down syndrome
(DS); the incidence and severity of these phenotypes, however, are highly variable. The relationship between
specific genes and phenotypes associated with DS has been studied for decades, but how modifier genes
affect the incidence and variability of DS phenotypes is not well known, and only a few attempts have been
made to identify two-copy or background genes that significantly modify DS phenotypes. Additionally,
differences in many skeletal and neurobehavioral phenotypes have been noted between males and females
with Ts21, but how sex modifies DS phenotypes has been understudied. More than twenty DS mouse models
have been developed to understand gene-phenotype relationships in DS, but the inbred genetic backgrounds
of all current mouse models do not offer an adequate landscape to analyze the impact of genetic diversity seen
in humans with DS. Moreover, limited study of the development of sex-specific phenotypes has hampered the
identification of the modifying causes of these traits. Additionally, how changes in the skeletal system may
affect cognitive and behavioral functions has not been extensively investigated. Our central hypotheses are
that novel, genetically robust DS mouse models will better represent the human condition and will facilitate
localization of modifier genes and molecular mechanisms linked to the variable sex-specific skeletal and
cognitive phenotypes associated with DS. The objectives of this project are to create new DS mouse models
that better represent the variability found in the human Ts21 genetic condition, identify modifier genes and
molecular pathways that lead to the variability in incidence and severity of DS skeletal and neurobehavioral
traits, and determine if skeletal improvements ameliorate brain-related phenotypes in DS mice. To achieve
these objectives, we will 1) create a diverse set of new DS mouse model lines to determine the overall
contribution of triplicated and non-triplicated background genes on the incidence and severity of skeletal
phenotypes associated with DS; 2) utilize an innovative QTL analysis of the new DS mouse model lines to
identify non-triplicated modifier genes most affecting the incidence and severity of sex-specific DS skeletal
phenotypes; 3) quantify modifiers of and changes skeletal and neurobehavioral measures after mechanical
stimulation of bone in a selection of the new DS mouse model lines. Our proposal is significant because it
establishes methodology to define gene-phenotype relationships for any DS phenotype, quantifies
mechanisms of modifying gens, and determines if there is a link between abnormal DS skeletal development
and functional brain deficits. This innovative work is in response to the NIH INCLUDE (INvestigation of Co-
occurring conditions across the Lifespan to Understand Down syndromE) request for new DS mouse models to
better define the pathophysiological effects of Ts21 and proposes a high-risk basic science study of the co-
occurring bone and brain traits to identify genetic pathways that may be most responsive to new DS therapies.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will create new mouse models that are more like the human Down syndrome condition to identify modifier genes and molecules contributing to the incidence and severity of DS skeletal and cognitive phenotypes, as well as differences between sexes in these phenotypes. This research will provide a foundation to change how the gene-phenotype relationships are deduced in Down syndrome and other syndromic disorders, propose relevant treatments, and ensure that that all children have the chance to achieve their full potential free from disease or disability.